Development of heparan sulfate-based therapeutics to treat inflammatory diseases

Abstract
More than 60 million Americans consume acetaminophen (APAP) on a weekly basis.
Unfortunately, an overdose of APAP causes liver toxicity and is responsible for over half of acute
liver failure cases in the US. N-acetyl cysteine is the only antidote for APAP overdose and is
effective if given within 10 hours after APAP ingestion. However, many patients don’t seek out
treatment during the therapeutic window for N-acetyl cystine. Currently, a liver transplant is the
only available treatment option for these late-presenting patients. APAP toxicity is a leading cause
for liver transplantation in the US and worldwide.
The goal of this SBIR phase II project is to develop an anti-inflammatory synthetic heparan sulfate
oligosaccharide, GLY-202, for APAP overdose patients specifically late-presenting patients. GLY-
202 was selected after compound optimization studies in efforts to identify a smaller, easier to
synthesize oligosaccharide with in vivo efficacy compared to 18-mer in the APAPoverdose model.
Unlike 18-mer, the synthesis of GLY-202 can be achieved in a shorter synthetic route,
substantially decreasing the production cost and reducing a significant commercialization barrier.
This phase II period will focus on IND-enabling studies including GLY-202 drug substance
chemical, manufacturing and control (CMC) activities (Aim 1), pharmacology (Aim 2) and toxicity
studies (Aim 3). Execution of the proposed aims will demonstrate synthetic scalability and
reproducibility in pilot production scale and efficacy and safety through pharmacology and toxicity
studies. During the phase II period, Glycan Therapeutics will submit an Orphan Drug Designation
application. Benefits of Orphan Drug status include significant financial benefits through fee
waivers and tax credits for clinical expenses. Furthermore, the clinical trial recruitment will be
comparatively small meaning that the amount of GLY-202 required can be sufficiently prepared
by Glycan Therapeutics. In the phase IIb studies, we will complete GMP manufacturing,
formulation, submit IND application and conduct Phase 1 clinical trials. The success of this project
will provide a new approach to treat drug induced liver toxicity by targeting to HMGB1-mediated
inflammation with a first-in-class therapeutic.

Public health relevance
Project Narrative Heparan sulfate is a sulfated polysaccharide displaying a wide range of biological functions. In this project, Glycan Therapeutics plans to examine the potency and efficacy to protect againsr acetaminophen-induced acute liver failure using heparan sulfate oligosaccharides. The heparan sulfate will achieve the hepatoprotection by inhibiting excessive inflammatory responses from the host. The success of the project will provide a new therapeutic to treat drug-induced liver failure.